Development and Pilot Evaluation of an Online Intervention to Prevent Dating Violence and Problem Drinking in Sexual Minority Youth

Purpose of the Administrative Supplement The purpose of this administrative supplement is to support the effort needed to meet the NIMH Data Archiving (NDA) requirements. The specific required activities associated with the NDA requirements are included in the Data Sharing and Archiving Plan attached to this supplement request application. The New NDA requirement places a significant burden on our study's budget. At the time of writing our grant we were not aware of the workload it would require adhering to the requirement and so we did not incorporate it into our study budget. In addition, our requested budget was cut by 10%. Given this, we are requesting a small amount additional funds to help us stay on track with this new NDA data submission requirement. We utilized the NIH spreadsheet to help us determine how much we may need in additional funding (see attached budget). We appreciate your consideration of this request to ensure the success of our study and more specifically the NDA requirements.

Public health relevance
Project Narrative Dating violence (DV) and alcohol use (AU) occur at alarmingly high rates among LGBTQ+ youth, and minority stress is a unique and critically important risk factor for DV and AU in LGBTQ+ youth, whereas the sense of community with other LGBTQ+ youth can serve as a protective factor. The overarching goal of the proposed project is to develop an innovative, online synchronous DV and AU prevention curriculum created specifically for LGBTQ+ youth (ages 15 to 18); conduct a pilot randomized controlled trial to assess its feasibility and acceptability of the intervention and study procedures; and identify preliminary outcomes of the intervention. The project focuses on two interrelated and significant public health issues (i.e., DV and AU), proposes an innovative approach to prevent them, and is highly consistent with the Healthy People 2020 goals of reducing violence and substance use and improving the health, safety, and well-being of LGBTQ+ individuals.